Understanding Mycobacterium tuberculosis 20S proteasome assembly

PROJECT SUMMARY
Tuberculosis affects over 8,000 individuals in the United States every year, with Mycobacterium tuberculosis
(Mtb) able to resist the immune system in part through proteasome function. The proteasome is the
macromolecular structure responsible for the degradation of misfolded or short-lived proteins in cells, and is
composed of four stacked heptameric rings in a barrel-like structure. The long-term goal of this work is to help
understand the mechanisms that regulate proteasome assembly in the Mtb system using both mathematical
modeling and experimental analyses. The overall objectives in this application are to (1) elucidate the
mechanism(s) by which assembly dynamics regulate proteasome formation and (2) determine their role in Mtb
proteasome assembly. The central hypothesis is that Mtb proteasome has evolved a set of mechanisms that
maximize yield and thus bacterial immune resistance. The rationale for this project is that determination of the
mechanisms that regulate Mtb proteasome yield is likely to offer a strong scientific framework whereby new
strategies for tuberculosis therapies in patients can be developed. The central hypothesis will be tested by
pursuing three specific aims: (1) Evaluate the assembly kinetics of the Mtb proteasome using mathematical
and experimental analyses, (2) Develop a biophysical framework to understand interactions between
intermediate rings in proteasome assembly and (3) Analyze structures of intermediate rings in Mtb proteasome
assembly. In the first aim, a mathematical model will be used to determine the role kinetic parameters play in
ring formation and ultimately proteasome assembly. Additionally, Mtb monomers will be used to experimentally
measure the kinetics of assembly. For the second aim, a biophysical framework will be developed to study the
interactions between monomers and intermediate rings based on their size and structure. Furthermore, a
mass-spectrometry approach will be used to identify the size and composition of intermediate rings formed
during Mtb proteasome assembly. In the third aim, a cryo-Electron Microscopy approach will be used to
analyze the structures of assembly intermediates with atomic resolution. The research proposed in this
application is innovative because it focuses on the Mtb proteasome, which has not been sufficiently
characterized to date, and because it incorporates both mathematical modeling and experimental methods.
The proposed research is significant because it is expected to provide a foundation for the development and
future clinical applications of novel Mtb proteasome assembly inhibitors. Ultimately, such knowledge has the
potential of offering new opportunities for the development of innovative therapies to treat tuberculosis and
other bacterial infections. Moreover, this fellowship is sponsored by Drs. Eric J. Deeds and Joseph A. Loo, who
are leaders in their respective fields of computational biology and mass spectrometry. The proposed training
plan includes a strong research environment and mentoring team conducive to the applicant’s growth into a
highly successful independent researcher.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on understanding the mechanisms that regulate Mycobacterium tuberculosis proteasome assembly, which provides the bacteria with immune system resistance. Once such knowledge is established, there is the potential for a significant advance in anti-bacterial infection therapies for patients. Thus, the current interdisciplinary proposal is relevant to the part of the NIH’s mission that pertains to reducing illness.